A PHASE I STUDY OF C34-CXCR4 MODIFIED CD4 T CELLS IN HIV-1 INFECTED INDIVIDUALS

In collaboration with Sangamo, we have previously employed the use of zinc finger nucleases (ZFN) to edit the CCR5 gene to generate HIV resistant CD4+ T cells. Building upon that success, and mindful of it limitations, our study aims to protect CD4 cells by expressing C34- CXCR4 to render them resistant to both R5 and X4 HIV. The hypothesis of our study is that autologous CD4+ T cells genetically modified with an HR2, C34-peptide conjugated to the CXCR4 N-terminus using lentiviral vector will be resistant to HIV infection in vivo in the setting of an analytical treatment interruption and will preserve and enhance an immunological response to HIV. In close collaboration with Projects 2, 3 and 4, and Cores A and B, we will evaluate in vivo C34- CXCR4-modified autologous CD4+T cells with 3 Specific Aims SA1: Complete pre-clinical testing necessary to support manufacturing of C34-CXCR4-modified autologous CD4+T cells. SA2: Conduct a proof of concept clinical trial to determine the safety of C34-CXCR4-modified autologous CD4+T cells in patients with well controlled viral replication. SA3: Evaluate the host and virological response to C34-CXCR4-modified autologous CD4+T cells.